ATRIAL NATRIURETIC PEPTIDE AND SALT SENSITIVITY

The purpose of this study is to determine if differences in genes coding for atrial natriuretic peptide (ANP) are related to salt sensitivity in humans.